Robust ultra-high sensitivity proteomic technologies for limited samples

PROJECT SUMMARY
The majority of highly diverse biological processes are enabled through proteins, protein post-translational
modifications/proteoforms, protein interactions, PIs (e.g., protein-protein, PPIs, protein- ligand, PLIs), and
aberrations of abundances, activities, functions, and integrity of such interactions can lead to severe diseases,
including cancer. Furthermore, disruption of these protein-based characteristics by novel targeted therapies
can be an important biomarker for the response to these drugs in personalized medicine approaches. Clinical
and biological specimens are often available in limited amounts, which greatly hampers the progress in
diagnostics, therapy development, and biomedical research. Microbiopsy and liquid biopsies containing rare
cell populations such as circulating tumor cells, hematopoietic stem cells (HSCs) and immune cells may
contain only low thousands or hundreds of cells and be heterogeneous. Traditional techniques to study
proteomic profiles, proteoforms, protein complexes, and PPIs (e.g., conventional proteomics, NMR, X-ray
crystallography, yeast two-hybrid screening and immunoaffinity purification (IP) followed by mass spectrometry
(MS)) cannot be readily used for the analysis of small cell populations, microscopic clinical samples and
individual cells mainly due to limitations in sensitivity. Therefore, many biological and clinically relevant studies
are not undertaken because of the lack of technology for such low level samples. Here, we propose to
develop analytical platforms that will enable high sensitivity analysis of scarce samples at the level of
digests, intact proteoforms, and native complexes. This task will demand the development of novel
approaches in sample preparation, ulra-low flow liquid phase separations interfaced with MS, MS data
acquisition, and data analysis. Developing such novel methods for thorough profiling of microscale samples
and integrating them in innovative “plug-and-play” automated platforms capable of efficient and high sensitivity
characterization of intact proteoforms, protein complexes and PTMs by MS will be highly desirable for gaining
biological insights into molecular mechanisms of the disease and discovery of therapeutic targets and
biomarkers for diagnostic and prognostic purposes. The developed platforms will be evaluated using well-
controlled model systems and applied in the most clinically relevant settings to examine (1) model systems for
cell differentiation and activation; (2) the interactome and biological role of STAT3, the transcription factor
which is aberrantly activated in the vast majority of ovarian cancer cell lines and primary samples; and (2)
MHC-associated neontigenic peptides.

Public health relevance
PUBLIC HEALTH RELEVANCE The proposed research will be focused on technology development for ultra-high sensitivity deep proteomic analysis of limited biological and clinical samples. Comprehensive proteome characterization of such samples at the level of digests, intact proteoforms, native non-covalent protein complexes, and protein interactions is presently an insurmountable challenge in bioanalytical research. The proposed technology offers an unprecedented opportunity for expanding our knowledge of molecular mechanisms of disease processes and identifying new paths toward the discovery of diagnostic and prognostic biomarkers using minuscule sample amounts. OMB No. 0925-0001/0002 (Rev. 08/12 Approved Through 8/31/2015) Page Continuation Format Page